Defining Mechanisms Governing Myc Stability and its Modulation by Aurora Kinase A

Project Summary/Abstract.
The Myc gene family encodes three highly conserved transcription factors (N-, c-, L-), known to be oncogenic
drivers in many cancers. Dysregulation of Myc proteins is estimated to drive 30% of all cancers, attributed to
inappropriate amplified Myc expression and dysregulated behaviors. c-Myc is prominent in a wide variety of
cancers, due to its broad expression patterns, where N-Myc and L-Myc are tissue specific and heavily associated
in neuroblastoma and small cell lung carcinoma, respectively. Due to its prevalent cancer involvement, Myc
family transcription factors are considered an attractive anti-cancer target, but their disordered nature makes
them poor drug targets. Protein-protein interactions of Myc with other regulatory partners creates an opportunity
for therapeutic intervention via indirect targeting, yet structural details of many Myc interactions remain unclear.
The N- and c-Myc binding partner Aurora Kinase A (AurA), a serine-threonine kinase, is hypothesized to stabilize
Myc by preventing proper ubiquitin-mediated degradation by the SCFFbxw7 ubiquitin ligase complex. In this pro-
posal, fluorescence anisotropy and time-resolved fluorescence will be utilized to fully assess binding of AurA at
varied phosphorylation states and lengths of c-Myc. To structurally characterize a c-Myc/AurA complex I will
pursue extensive training in X-ray crystallography alongside my experience using continuous-wave electron par-
amagnetic resonance (CW-EPR) spectroscopy to study the interface of this interaction, proposed within. My
preliminary work has supported the formation of an AurA/c-Myc/Fbxw7 complex, of which I will structurally char-
acterize using continued training in cryogenic-electron microscopy (cryo-EM). Further characterization of c-Myc
stabilization and ubiquitination patterns by AurA using my developed in vitro ubiquitination assays will result in a
defined mechanism of AurA induced stabilization of c-Myc. The high conservation of regulatory protein binding
domains across Myc family transcription factors suggests a role of AurA stabilization of L-Myc, already identified
for N- and c-Myc. The work and training I receive studying the c-Myc/AurA interaction will build foundations for
my future independent research on defining an impact of AurA on L-Myc stabilization, a widely understudied Myc
family member. I will also use in cellular work to characterize the physiological protein interactions involved in L-
Myc regulation and dysregulation, including kinases and SCF ubiquitin ligase components, currently unidentified.
The extensive X-ray crystallography and cryo-EM training proposed within will add a strong structural biology
foundation to the independent research program I plan to develop at an R1 institution. The focus of my lab will
be rooted in characterizing the regulation mechanisms of disordered transcription factors in cancer and disease.
I believe the extensive structural biology and biophysical background from proposed training and extensive ex-
perience will make me a competitive candidate for a future tenure-track faculty role.

Public health relevance
Public Health Relevance. In this proposal I will characterize mechanisms of regulation and induced stabilization of the oncogenic Myc family transcription factors, specifically the stabilizing influence of Aurora Kinase A (AurA). These AurA-Myc in- teractions and other regulatory protein interactions will be structurally characterized and probed in cancerous cellular environments to determine their physiological relevance. These studies will serve as a basis for under- standing the mechanisms governing Myc dysregulation, responsible for 30% of all cancers.